Core C: Biostatistics Core

PROJECT SUMMARY/ABSTRACT
Core C will provide essential data and analytics support to investigators on the Northwest Prostate Cancer
SPORE. This Core will link study design, data collection, measurement, and analysis to validly address the
critical hypotheses and questions of the Pacific Northwest Prostate Cancer SPORE through the following
Specific Aims:
Specific Aim 1: Study design
Define study hypotheses, study populations, and experimental parameters to answer the research questions of
interest, reduce systematic bias, and ensure a high likelihood of detection of biologically meaningful effects. As
part of this aim Core C will provide power calculations when needed for each project.
Specific Aim 2: Analysis and interpretation
Identify and implement quantitative methods to address the scientific questions of interest and provide valid
statistical inferences about the evidence addressing the various study hypotheses. Work with study investigators
to clearly communicate methods and results in study publications and insure that reported conclusions are
justified.
The Biostatistics Core is integral to the collection, validation and analysis of data for SPORE projects. Further,
where appropriate statistical methods are inadequate or lacking, Core personnel devise and implement novel
analytic approaches. The Core will provide: (1) prompt responsiveness with respect to biostatistical and
bioinformatics analyses; (2) appropriate expertise to select and implement an optimal approach to study design
and analysis; (3) customized dataset creation and analysis; and (4) clear communication of study findings,
conclusions, and limitations to investigators and the broader community.

Public health relevance
PROJECT NARRATIVE The Biostatistics Core is a shared resource Core that links study design, data collection, measurement, and analysis to validly address the critical hypotheses and questions of the Pacific Northwest Prostate Cancer SPORE.